Cadmium and Arsenic Effects on Pyrimidine Biosynthesis in Early Airway Development

Abstract
Derangements in airway branching morphogenesis caused by prenatal exposures can have lifelong adverse
impact on lung function and increase risks for many major respiratory diseases. Adverse effects of prenatal
exposures to alcohol and nicotine are well demonstrated, but the impact of environmental exposures on fetal
airway development is less understood. Exposures to heavy metals such as cadmium (Cd) and arsenic (As)
are linked to compromised lung health in children and adults. Cd and As cross the placental barrier and are
detected ubiquitously in pregnant women, newborns, and children. They are a major public health concern at
the US population level, punctuated by alarmingly high exposures in specific communities. Because prenatal
exposures to Cd and As are widespread and can have long-term effects on respiratory function, disease risks
and prognosis, studies addressing the mechanisms of Cd and As impacting airway development are of urgent
and fundamental importance. This application focuses on a novel yet central metabolic pathway, pyrimidine
synthesis, found to drive defects in airway branching morphogenesis by our prior research. Pyrimidines are
precursors for DNA and RNA synthesis, protein modification and lipid production, and play major regulatory
roles in cell growth, proliferation, and differentiation. We hypothesize that dysregulation of de novo
biosynthesis of pyrimidines is a critical factor contributing to abnormal airway development and
growth. Pyrimidine synthesis is directed by multiple regulatory mechanisms, many susceptible to disruption by
heavy metals; the tight control of this pathway is essential to balance between compromised lung development
and cancer risk. We will capitalize on established experimental models and use a quantitative and systematic
approach, leveraging metabolomics and fluxomics for quantification of affected metabolic flux, linking single-
cell transcriptional network variations to the metabolic impact, and evaluating pathological phenotypes with
quantitative assessment of airway structure and function. Aim 1 will focus on Cd and As effects on DNA and
RNA synthesis as direct output of pyrimidine synthesis and establish a quantitative foundation for studying cell
proliferation controlled by nucleic acid precursor availabilities. Aim 2 will focus on proteoglycans, an important
mediator of growth factor signaling, which require the pyrimidine, uracil and its products, UDP-sugars for
biosynthesis. We will take an innovative approach to investigate the interactions of cell-type specific
transcriptional activities and metabolic signals in the form of complex and dynamic networks. Aim 3 will focus
on synthesis of phosphatidylcholine in early airway development, the most important component of cell
membrane bilayers, which require CTP, and its product CDP-choline as the precursors. Finally, Aim 4 will
determine early postnatal lung structure and function to provide information for future translational research on
early indicators of Cd and As induced airway developmental abnormalities.

Public health relevance
Project Narrative Prenatal exposure to unsafe levels of heavy metals such as cadmium and arsenic through food and drinking water is an unavoidable risk factor concerning communities with disproportionately high burden of airway disorders, healthcare disparity and environmental injustice. There are no effective prevention and intervention strategies against prenatal exposures due to the lack of understanding in abnormal vs normal airway development modulated by environmental stressors. This application will provide critical mechanistic information on how prenatal exposures at human-relevant levels quantitatively impact airway development and growth in mouse models.